Models and mechanisms of SCN3A neurodevelopmental disorder

Pathogenic variants in the gene SCN3A, which encodes the voltage-gated sodium (Na+) channel subunit
Nav1 .3, cause SCN3A-related neurodevelopmental disorder (SCN3A-NDD), a recently identified condition
defined by treatment-resistant epilepsy, severe to profound intellectual disability (ID), and, surprisingly,
malformation of cortical development (MCD; abnormal structural development of the cerebral cortex). There is
no known role for Na+ channels in structural brain development nor any basis for brain malformation caused
by Na+ channel variants, and it remains unclear how genetic variants in SCN3A lead to MCD, epilepsy, and/or
ID. This proposal seeks to define the mechanistic underpinnings of this poorly understood disorder in order to
define the normal physiological role of Nav1 .3 and to inform therapeutic discovery or preventative measures for
SCN3A-NDD, a devastating disease which currently has no treatment or cure.
The prominence of MCD among our uniquely large patient cohort combined with known high embryonic
expression of SCN3A in the brain motivates my central hypothesis that pathogenic variants in SCN3A cause
epilepsy and MCD in SCN3A-NDD by producing pathological Na+ currents in developing cortical neurons
leading to perturbed excitability and altered neuronal migration. Proposed experiments will functionally assess
specific patient variants in SCN3A in our cohort and establish the relationship between individual genetic
variant, channel dysfunction, neuronal excitability, structural development, and clinical presentation. Aim 1 will
ascertain the link between genetic variation in SCN3A and Na+ channel dysfunction by determining the
biophysical properties of wild-type versus variant Nav1 .3 in a transiently transfected (HEK-293T) cell system.
Aim 2 will assess how altered channel activity impacts neuronal electrical excitability, anatomy, and maturation
via generation of human excitatory cortical neurons derived from control or SCN3A variant-expressing induced
pluripotent stem cell (iPSC) lines. A novel Nav1 .3-selective compound PF-6651385 will be employed to
determine potential to pharmacologically correct dysfunction at the level of the channel (Aim 1) and/or neuron
(Aim 2).
This proposal using advanced model systems to interrogate pathogenic mechanisms of SCN3A-NDD will
advance my training towards a career in translational neuroscience while providing novel insight into a
potentially fundamental role for a Na+ channel in brain development and elucidating pathomechanisms
underlying SCN3A-NDD to progress towards targeted therapies for patients suffering from this disorder.

Public health relevance
SCN3A-related neurodevelopmental disorder (SCN3A-NDD) is a recently identified condition caused by pathogenic variants in the gene SCN3A encoding the voltage-gated sodium channel subunit Nav1 .3; this syndrome is defined by treatment resistant epilepsy, severe to profound intellectual disability, and, unexpectedly, malformation of cortical development, yet how sodium channel function might regulate brain development and channel dysfunction lead to brain malformation is entirely unknown. The objective of this proposal is to investigate how variants in SCN3A lead to these complex neurological phenotypes including epilepsy and structural brain malformation. The work proposed here will link across levels of analysis from human genetics, to ion channel and neuronal dysfunction, to clinical phenotype, in order to inform therapeutic discovery or preventative measures for this devastating disorder which is currently without treatment or cure.